Self-test HIV diagnostics utilizing structurally novel, shark-derived binding domains

PROJECT SUMMARY
Since the first serologic tests were introduced at the peak of the AIDS crisis in the 1980s, continuous improvements
in diagnostic technology have enabled the earlier detection and routine monitoring of HIV positive individuals. However,
there are two areas where current HIV diagnostics fall short of ideal, and which we will attempt to directly address in this
proposal; the first is the need for a simple diagnostic tool that allows individuals to self‐test for acute phase HIV infections.
The second challenge is the provision of a diagnostic tool that will allow patients previously diagnosed as HIV positive to
monitor their viral load following ART interruption or check for loss of viral control due to the emergence of drug‐
resistance. Given these diagnostics are to be used in a patients own home (or other non‐clinical, setting), they need to be
cheap, robust, and suitable for use without prior training or specialist equipment. Further, they should use a biological
sample that can be obtained in a minimally invasive manner (e.g. a finger‐stick blood drop) to encourage frequent retesting
in target populations.
To address the above problems, we will integrate two existing technologies to generate a sensitive home‐test
diagnostic for HIV. The first technology is a structurally novel binding domain, so called VNARs, that we isolate from
immunized sharks. Despite their diminutive size (12kDa), the VNAR domains raised thus far have binding affinities equal
to classical antibodies but are intrinsically much more chemo‐ and thermostable. VNARs interact with antigen in unique
ways and can be raised against epitopes that are inaccessible to conventional antibodies; we will exploit this fact to target
the HIV proteins p24 and Env, allowing us to capture and accurately quantify free proteins or whole virus in unmanipulated
blood. We will integrate these VNARs with our second technology, the programmable Bio‐Nano‐Chip (p‐BNC), a microchip‐
based detection system which utilizes porous agarose microbeads as 3D diagnostic surfaces. Immunometric assays can be
performed by loading the beads with biomolecules such as antibodies, or in this case VNARs, allowing the capture and
quantitation of desired target(s) in biological samples. To enable use of this technology in a non‐clinical setting, we will
develop credit card‐sized diagnostic cartridges that have a microbead‐based sensor array at their core, and microfluidic
system for the delivery of sample, wash buffer, and detection reagent. This will be deployed and read by a battery‐
powered handheld reader system that will be developed and fabricated during our project. This system will use an imaging
system derived from smartphones and enable the safe and secure uploading of data to a cloud‐based repository. Together
these technologies will allow us to deliver an inexpensive, robust, sensitive, and accurate diagnostic test that can be used
by an individual to assess their HIV status or closely monitor their viral load, without a clinic visit.

Public health relevance
PROJECT NARRATIVE Antiretroviral therapy has greatly improved the lives of HIV positive patients, reducing their risk of progressing to full blown AIDS and the likelihood that they will pass the virus to their partners. However, delayed diagnosis, interruptions in treatment, or the emergence of drug resistant virus all put these patients at risk. The aim of this project is to develop a new HIV test that can be performed by an individual in their own home or other non‐clinical environment without specialist equipment. To do this we will exploit a novel molecule, found only in sharks, for the efficient detection and quantification of virus in unmanipulated samples such as blood.